Repository Services for epidemiology studies

Under this project, a state-of-the-art repository for the storage of biospecimens for human epidemiology is operated. The repository activities include: sample receipt and distribution; ambient and low temperature storage of environmental and biological specimens; computerized sample inventory maintenance; maintain QC and QA programs; development or identification of biospecimen collection and storage conditions to preserve specimen and target analyte integrity; support to field centers in collection procedures, equipment, materials, and sample transportation, as requested. Support for Human molecular epidemiology research is focused in the following areas: Acute Myeloid Leukemia ? Adenocarcinoma ? Aplastic Anemia ? Breast Cancer ? Burkitt's Lymphoma ? Chronic Lymphocytic Leukemia ? Colorectal Cancer ? COVID-19 ? Endometrial Cancer ? Esophageal Cancer ? Ewing Sarcoma ? Fanconi Anemia ? Helicobacter pylori (H. pylori) ? Hodgkin Lymphoma ? Kidney Cancer ? Li-Fraumeni Syndrome ? Lung Cancer ? Melanoma ? Myelofibrosis ? Myotonic Dystrophy ? Neurofibromatosis 1 ? Non-Hodgkin Lymphoma ? Osteosarcoma ? Ovarian Cancer ? Pancreatic Cancer ? Pituitary Cancer ? Prostate Cancer ? Rhabdomyosarcoma ? Thyroid Cancer ? Waldenstrom Macroglobulinemia